Mechanisms of the signaling metabolite β-hydroxybutyrate in Alzheimer's disease and the aging brain

PROJECT SUMMARY
Signaling metabolites are small molecules with routine functions in cellular energy metabolism that also
act as signals to regulate diverse cellular pathways in response to a changing energy state. Signaling metabolites
link nutrition to aging. Many of the emerging geroscience therapies that target mechanisms of aging have come
from the discovery and understanding of signaling metabolites. The ketone body β-hydroxybutyrate (BHB) is a
new signaling metabolite. It is produced during fasting, dietary restriction, exercise, or carbohydrate restriction
to keep the body's tissues supplied with energy when glucose is scarce. We now have growing evidence that it
also functions as a signal, by inhibiting enzymes, binding directly to proteins as a post-translational modification,
and activating receptors. Through its signaling activities, BHB regulates gene expression, inflammation,
metabolism, senescence, and other cellular activities important to both aging and Alzheimer's disease (AD).
We recently showed for the first time that ketogenic diet (KD), which stimulates endogenous production
of BHB similar to fasting, improves survival in aging mice and prevents age-related declines in memory. We also
found that KD improves memory in the hAPPJ20 AD mouse model, and reduces abnormal epileptiform
discharges that contribute to memory decline. KD is a complex intervention, and though it is now being studied
in clinical trials of AD, a better understanding of which aspects of KD are most helpful should lead to better
targeted and more effective therapies. We have successfully developed an innovative toolset of dietary,
chemical, and genetic tools to isolate the individual components of KD, including carbohydrate restriction, BHB,
energy provision by BHB, and cellular signaling activities of BHB. We will use these tools to uncover the specific
mechanisms by which BHB improves memory in normal aging and in AD mice (Aim 1), and reduces epileptiform
discharges in AD mice (Aim 2). We will characterize key molecular changes that BHB causes in the proteomic
landscape of the brain, including mapping the acetylome and new BHBylome (Aim 3).
This project combines expertise in both geroscience and AD with a deep understanding of BHB biology
to carry out closely aligned mechanistic studies using both aging and AD models. It examines the intersection of
a molecular mechanism that is broadly relevant to aging (ketone bodies as metabolic signals) with one highly
specific to AD (aberrant epilepsy-like network hypersynchrony). It is highly likely to stimulate further progress on
AD because the mechanistic framework it generates will directly inform translational studies involving ketone
body compounds and ketogenic diets. These data will help establish criteria for designing effective interventions,
provide relevant intermediate biomarkers, and permit deeper investigation into the downstream molecular targets
most relevant to AD.

Public health relevance
PROJECT NARRATIVE A low-carbohydrate ketogenic diet replicates some of the biological features of fasting or dietary restriction, and like these has recently been shown to improve lifespan and age-related memory decline in laboratory mice. Ketogenic diets are also being investigated in the treatment of Alzheimer's disease, although the mechanism by which it might work is unclear. This project will determine the specific mechanisms of ketogenic diet that improve memory both in normal aging and in Alzheimer's disease models, in order to create new therapies that target both the features of Alzheimer's disease and of the aging brain in which it occurs.